INTERFACIAL STRUCT OF PHOSPHATIDYLCHOLINE GRAFTED SILICA MATERIALS BY COLD XPS

The achievement of blood compatibility through the "mimicry" of the surface of platelet and red blood cell membranes is the goal of this project. A modified phospholipid fatty acid chain is covalently grafted to an aminated surface (e.g. glass, polypropylene, or PTFE), resulting in a surface containing a number of exposed polar head groups of phospholipid molecules. Earlier work showed a significant reduction in the number of adherent platelets on phosphatidylcholine-containing glass. AFM images suggested that the grafted molecule reorganizes when hydrated; cold-stage XPS is being employed at NESAC/BIO to study the surface in its hydrated state. Initial results suggest that the polar head groups are not at the outermost surface in the hydrated state.